Generation of a Transgenic Mouse Model to Study Human TLR9 Role in Disease

DESCRIPTION (provided by applicant): Toll-like receptor 9 (TLR9) is the receptor for un-methylated CpG motifs in DNA which are highly represented in bacterial DNA. Two aspects of TLR9 biology are the subject of intense research in both academia and the pharmaceutical industry: 1) using agonists of the receptor to augment the immunogenicity of antigens in vaccine and to treat cancer and allergic diseases of the lung, and 2) blocking the receptor to treat inflammatory disorders. In humans, TLR9 expression in mononuclear blood cells and lymphoid organs is restricted to B cells, plasmacytoid dendritic cells (PDC), and activated neutrophils, while in mice its expression is much broader, including macrophages, myeloid DCs, activated T cells, and NK, in addition to PDCs and B cells. In mice, in vivo, triggering of TLR9 leads to an overwhelming production of pro-inflammatory cytokines such as IL-12, TNF-α, and IL-6, but very minimal type I IFN, which in humans is the predominant response following TLR9 engagement. These differences in cellular responses represent a significant limitation to the value of using mouse models to study TLR9 biology and to predict the therapeutic potential of targeting this receptor for treatment of human diseases. To obviate this problem, we propose to generate transgenic mice expressing functional human TLR9 with a human-like distribution. The specific goals of this proposal include: 1) to characterize huTLR9 transgenic mice, 2) to assess the impact of a human-like TLR9 distribution in well-established models of inflammation in which mTLR9 is known to play an important role, and 3) to evaluate whether a human-like TLR9 distribution affects the therapeutic outcome of TLR9-agonist-mediated antitumor response. This mouse model will be an invaluable resource to everyone studying the role of TLR9 in disease and developing drugs targeting the receptor.

Public health relevance
PUBLIC HEALTH RELEVANCE: Much evidence points to the therapeutic potential of targeting TLR9 (a protein that plays a key role in the innate immune system), both by blocking and by activating the receptor; however, conclusions regarding TLR9 biology and the therapeutic efficacy of agents targeting TLR9 have been drawn from studies in mice, which have a very different distribution of this receptor among their blood cells than humans do. These differences represent a significant limitation to the value of using mouse models to study TLR9 biology and to predict the therapeutic potential of targeting this receptor for treatment of human diseases. Here we propose to generate a novel mouse model that expresses human TLR9 instead of mouse TLR9, which would be useful to study the role of TLR9 in a number of human diseases, including inflammatory disorders, and for developing vaccines for treatment of infectious diseases and cancer.